Admin Core

PROJECT SUMMARY: ADMINISTRATIVE CORE
The Administrative Core of the Great Lakes Center for Fresh Waters and Human Health (the Center) at the
University of Michigan (UM) will manage fundamental research and community-based projects ultimately
focused on understanding and mitigating toxic cyanobacterial Harmful Algal Blooms (cHAB) risks in the Great
Lakes, especially in Lake Erie. Western Lake Erie has been plagued by cHAB blooms for the last decade, and
recent bloom events have resulted in exposure risks that led to the complete shutdown of the Toledo (OH)
water supply in 2014. The Center’s Administrative Core is focused on supporting and coordinating four
integrated research projects, a Community Engagement Core and a Facility Core to ensure progress toward
our stated goals of understanding and translating climate change effects on cHAB events and their impact on
human health in the lower Great Lakes. A Director, Director Emeritus, and Co-Director will lead the
Administrative Core; they will be responsible for reporting progress and outcomes of Center activities. They will
meet monthly with the Internal Steering Committee, which will oversee coordination of research and of
community outreach and public policy, data management and budget management. Relevant research results
and potential policy outcomes will be communicated to state agencies and NGOs as they emerge. The
Administrative Core will be assessed by an External Advisory Committee (EAC), staffed by scientists outside of
the participating institutions, as well as representatives from state agencies and NGOs. The Center for
Educational Design, Evaluation and Research (CEDER) at UM will work with the EAC to conduct the
assessment with a utilization-focused evaluation and including formative and summative process and
outcomes evaluation components. Communication from the Center with other OHH Centers will promote
collaboration and data sharing where appropriate.